The effect of endogenous GLP-1 secretion on islet function in vivo

We have recently demonstrated that, in humans, islet function is dependent on Glucagon-Like Peptide-1 (GLP-
1), presumably originating in the α-cell. Islet GLP-1 regulates insulin and glucagon secretion and its effects
seem to be more important in type 2 diabetes. However, these observations raise additional questions which
we seek to address in this application. The first is whether the isolated defects in the regulation of fasting or
postprandial glucose tolerance, seen in prediabetes, represent selective failure of islet GLP-1 to support islet
function. Accordingly, we will use GLP-1 receptor blockade with exendin 9-39 to better understand the role (or
lack thereof) of islet GLP-1 in the pathogenesis of prediabetes. At present we do not know how the system is
regulated. Rodent models suggest that factors secreted by the β-cell in response to agonism of the β-cell’s
GLP-1 receptors regulate expression of the prohormone convertase enzyme necessary to convert proglucagon
to GLP-1. This is testable in humans with and without functional β-cells. Their response to exendin 9-39 will be
compared before and after 4-week treatment with a GLP-1 receptor agonist. The experimental design will also
establish if the system is affected by glycemic control and weight loss. Finally, a common genetic variant in
TCF7L2 predisposes to type 2 diabetes through effects on α- and β-cell function. However, the mechanism by
which it does so remains obscure. TCF7L2 is a transcription factor that mediates proglucagon gene expression
in endocrine-derived cells, driving GLP-1 expression in enteroendocrine cells. Therefore, we will test the
hypothesis that the diabetes-associated variant at this locus (rs7903146) impairs islet production of GLP-1
thereby impairing islet function. The proposed experiments will help to understand the role and regulation of
islet GLP-1, furthering our ability to prevent type 2 diabetes.

Public health relevance
Production of GLP-1 within the islet is important in maintining islet function and glucose homeostasis. However, it is unclear as to how the system is regulated and how it adapts (or fails to adapt) in prediabetes and diabetes. Our proposed experiments will address these questions thereby identifying new ways to prevent and treat type 2 diabetes.